MEMBRANE SPANNING REGIONS AS PROTEIN-PROTEIN INTERACTING DOMAINS IN HIV

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The ability of the membrane-spanning region of the HIV-1 gp41 envelope glycoprotein to interact with itself and with corresponding regions in cellular transmembrane proteins is being investigated.